Advanced Side Impact Head Protection Technology for Child Safety Seats

Project Summary/Abstract
Minnesota HealthSolutions Corporation (MHS) proposes to develop a novel dynamic headrest for child safety seats
to reduce head injuries in crashes with a side impact. Side impact crashes cause disproportionately higher rates
of head injuries and fatalities compared to other crash directions, yet historically child safety seats were designed
and tested for head-on crashes. Recent efforts to mitigate head injuries to children in side impact crashes have
resulted in larger wings attached to the headrest. However, in side impact crashes, children's heads frequently
move both forward and laterally, and larger wings do not contain children's head. Research has shown that side
wings have little to no effort on head containment or head excursion. We hypothesize that a child safety seat
with a dynamic headrest that requires no change in user behavior will reduce head-related injuries to children in
crashes. An interdisciplinary team of researchers has been assembled to define, build, and evaluate a prototype
system.

Public health relevance
Project Narrative Motor vehicle crashes are a leading cause of unintentional morbidity and mortality among children in the United States and a leading cause of brain injury. In the past ten years, thousands of children have died in unintentional crashes and millions more had hospital-treated injuries. We aim to develop an enhanced child safety seat that better protects children in side impact crashes.